Enhanced kidney follow-up for AKI survivors in Care Transitions (the ACT Study)

PROJECT SUMMARY/ABSTRACT
Acute kidney injury (AKI) confers a significant risk of poor short- and long-term health outcomes, with 49% of
survivors re-hospitalized within 1 year, a 1.5-2.5-fold higher risk of chronic kidney disease and1.4-fold higher
risk of cardiovascular events. This significant risk of poor outcomes can be partially attributed to gaps in
kidney-focused care and education during transitions. Nephrotoxin use remains highly prevalent in AKI
survivors, which is a potential modifiable determinant of long-term outcomes. With existing models, 30% of
patients who survive an episode of moderate to severe AKI fail to receive a serum creatinine check and a clinic
visit in the 30-days after discharge, two core components of adequate kidney follow-up. There is a critical need
to develop new transitional care models for AKI survivors and to evaluate their impact on clinical and patient-
centered outcomes. To address this need, the overall goal of this proposal is to enhance post-AKI care quality,
outcomes, and experience through the AKI in Care Transitions (ACT) program. ACT is a bundled intervention
that includes early identification of high risk AKI survivors with an electronic indicator, nurse education and care
coordination prior to hospital discharge, with a post-discharge follow-up visit within 7-14 days by provider and
pharmacist in the patient’s medical home, primary care. The proposal aims to 1) Determine the preliminary
efficacy of the ACT program to improve clinical and patient-reported outcomes and, 2) Evaluate the feasibility
and acceptability of the AKI in Care Transitions pilot and iteratively refine the intervention. In Aim 1 we will
conduct a pilot pragmatic clinical trial in 50 AKI survivors. Patients will be randomized 1:1 to either the ACT
intervention or usual care. The primary outcome assessed in an intention-to-treat analysis will be kidney
knowledge and secondary patient reported and clinical outcomes to be measured in the 6-months after
discharge will include health literacy, quality of life, hospital readmissions, recurrent episodes of AKI, kidney
function, and nephrotoxin use. Aim 2 uses a convergent mixed methods study design to evaluate the feasibility
and acceptability of the ACT intervention from the perspective of patients and clinicians. Feasibility will be
measured by proportion of patients who complete each aspect of the ACT workflow, and acceptability will be
characterized with 20 qualitative interviews and direct observation of 10 nurse education and follow-up visits.
The ACT intervention will be iteratively refined based on these insights to reduce potential barriers to
implementation in a larger trial or clinical practice. This innovative proposal uses an efficient, coordinated, care
transition model to enhance kidney health, knowledge, and safety in a high risk group of patients with existing
gaps in care quality. The ACT pilot is directly aligned with the AHRQ mission to make healthcare safer, of
higher quality, and more accessible, equitable, and affordable.

Public health relevance
PROJECT NARRATIVE The Acute Kidney Injury in Care Transitions (ACT) program supports patients preparing to discharge from the hospital to home after an episode of short term kidney dysfunction, termed acute kidney injury. This work is aligned with the AHRQ mission as it proposes an innovative, scalable model to make post-AKI care safer, of higher quality, more accessible, equitable, and affordable. We aim to evaluate the efficacy, feasibility, and acceptability of a new care transition model for patients that uses a team of providers to deliver education and focused kidney health follow-up to improve knowledge, outcomes, and quality of life.